Connectomes-related to Active Methamphetamine-dependence Project (CAMP)

Despite reports of declining methamphetamine use in the early 2000’s, psychostimulant-related overdose
deaths in the US, of which methamphetamine is primarily involved, increased ~1,800% from 1999-2017.
Currently, identifying IDM who are in the greatest need for intervention is only discovered after catastrophic
events have occurred (e.g., overdose, arrest, job loss). Thus, there is an urgent necessity for objective means
of identifying IDM at-risk for such devastating consequences, before these consequences can occur.
Previous studies have shown correlations between independent measures of biological, psychological, and
social factors and critical outcomes (e.g., substance use patterns) in individuals dependent upon
methamphetamine (IDM). However, no research has leveraged the combined power of biological,
psychological, and social measures to the predict outcomes in IDM. Recent success combining neuroimaging
(biological) and psychosocial measures with advanced machine-learning techniques to predict treatment or
diagnostic outcomes in substance use and other disorders establish a precedent for achieving similar
success in IDM. This project seeks to collect the first ever neuroimaging (magnetic resonance imaging [MRI],
psychological (e.g., anxiety, depression, and psychosis symptoms), and social (e.g., interpersonal violence
histories, peer network drug use) dataset from IDM (Aim 1). MRI data will be collected using state-of-the art
sequences adopted from the Human Connectome Project and all data will made openly available allowing
for the global scientific community opportunities to gain limitless insights from these unique data. Here, data
will be used in machine-learning models for the prediction of two critical outcomes in IDM: substance use
patterns and occupational functioning over a 6-month time period (Aim 2). Machine-learning models
developed as part of this project will result in future funding proposals focusing on extending longitudinal
analyses (e.g., 3-5 years) and acquiring additional participants for model evaluation. The long-term goal of
this research is the development of predictive models quantifying an IDM’s probability of improving or
worsening addiction and addiction-related consequences. In this way, this project will provide the foundation
for objective, biopsychosocial models tailored toward the prediction and eventual prevention of greater harms
to IDM.